Administrative Supplement: Surveying transcription factor pioneer interactions with nucleosomal DNA

Project Summary The goals of this administrative supplement project are to undertake systematic evaluation of a subset of the protein capture reagents (antibodies) that have been generated by the NIH Common Fund Protein Capture Reagents Program (PCRP). Our goals are to: (1) validate each antibody by Western blot analysis; (2) evaluate each antibody by protein binding microarray (PBM) or other in vitro DNA binding assay; (3) evaluate a subset of the antibodies by ChIP-Seq; (4) generate a 1-page report file for each antibody from each validation assay. These validation assays will evaluate the ability of these antibodies to recognize their target transcription factors in solution and also when bound to DNA in vitro and, for a subset of transcription factors, in vivo. These validation assays will extend the utility of the PCRP capture reagents as a resource to the community by demonstrating the utility of the capture reagents to recognize transcription factors bound to DNA.

Public health relevance
Project Narrative In this project we will evaluate antibodies generated by the NIH Protein Capture Reagents Program (PCRP) for human transcription factors. The validated antibodies will allow for further characterization of this important class of regulatory factors.